Dominantly Inherited Alzheimer Network: Clinical Core

Core B: Clinical PROJECT SUMMARY
The Dominantly Inherited Alzheimer Network (DIAN), Core B: Clinical is responsible for the protocol
implementation of all clinical operations for the research studies, including participant recruitment, retention,
and protection, performing clinical evaluations including CDR and psychometric testing, completing imaging,
blood and CSF collections, and offering genetic counseling and testing. The study of longitudinal progression
of dominantly inherited Alzheimer disease will likely lead to a better understanding of the causes of Alzheimer
disease. DIAN studies inform about potential methods of detecting AD and the sequence of events at the
earliest stages of the illness, even before clinical symptoms have begun. The DIAN-Observational study will
continue to support and enable preventative treatments to be tested.
The Clinical Core will obtain highly sensitive clinical evaluations to determine the earliest symptoms and
progression rates. A remote assessment platform will be added to aid in the study of lifestyle factors as
contributors to disease heterogeneity. The longitudinal study of cognitive and clinical measures will be
analyzed by estimated years to symptomatic onset and followed longitudinally to estimate progression and
rates of change. The data generated from these studies will be used by DIAN investigators to advance the
understanding of the causes of Alzheimer disease, methods of early detection, and support ongoing and future
preventative treatments.